Function of Chromatin Features in Cellular Programming

PROJECT SUMMARY / ABSTRACT
Maintaining stable gene transcription patterns is critical for cellular programming. Likewise, orderly switching
from one transcription pattern to another, termed reprogramming, is necessary for development, as well as for
numerous other biological processes. Dysregulated reprogramming can have catastrophic consequences, with
outcomes ranging from developmental disease to cancer. Notably, epigenetic abnormalities, failure to
differentiate, and inappropriate cellular programming are intricately linked to carcinogenesis. Our objective is to
define the function of H2A.Z (a variant form of histone H2A) in regulating cellular programming. We will utilize
cultured mouse cells, human cancer cells, and developing zebrafish embryos, combined with a series of next-
generation genome-wide sequencing approaches, to functionally test how H2A.Z patterns regulate several
aspects of cellular reprogramming, including transcriptional activation. Our prior studies have uncovered
considerable diversity in H2A.Z function, including regulation of chromatin accessibility, transcription factor
binding patterns, bivalent chromatin establishment, and nucleosome remodeler function. One interesting
possibility is that H2A.Z interacting proteins influence its genomic localization and mediate its function. To test
this hypothesis, we will genetically manipulate the regulators of H2A.Z localization in zebrafish embryos, and
cultured mouse cells, and then assess outcomes via genomics and proteomics studies. Successful completion
of this project will define the role of H2A.Z in controlling gene expression patterns and in cellular programming.
We propose that this broader concept, where changes in epigenetic marks underlie cellular reprogramming,
might be a general principle in biology, with relevance to developmental biology, stem cell function, and
carcinogenesis.

Public health relevance
PROJECT NARRATIVE Precise control over gene expression programs is critical for cellular differentiation, and when control is lost, outcomes can be tragic, ranging from developmental disorders to cancer. Therefore, understanding how chromatin and epigenetic marks control gene expression will be highly beneficial for preventing and treating diseases in which cellular programming defects are central. This project defines how interplay between chromatin elements and transcription factors regulates gene expression programs and cellular programming in vertebrates.